An intervention to reduce sedentary behavior for Black adults with chronic kidney disease: RESET-CKD

Project Summary
The purpose of this K23 Mentored Patient-Oriented Career Development Award application is to support the
applicant’s long-term goal to develop an independent research program focused on improving the health and
quality of life for adults with chronic kidney disease (CKD) through healthy lifestyle behaviors, with a particular
focus on underrepresented minority populations. Black adults are disproportionately affected by CKD and have
some of the worst health outcomes among those with CKD. Adults with CKD are extremely sedentary, and the
poor health outcomes associated with CKD may be modifiable by addressing sedentary behavior- a lifestyle
behavior associated with adverse health consequences. Theory-based behavioral interventions can effectively
reduce sedentary time, but research is lacking on theory-based sedentary reducing interventions adapted to
meet the unique needs of the at-risk population of Black adults with CKD. The overall goal of this award is to
adapt an evidenced-based intervention to reduce sedentary time for Black adults with CKD guided by patient-
centered design. During Aim 1, an evidenced-based sedentary reducing intervention will be adapted to
address unique factors that influence sedentary behavior for Black adults with CKD. Adaptation of the
intervention will be led by a Patient Advisory Board comprised of Black adults with CKD. In Aim 2, we will
conduct a 12-week pilot randomized controlled trial of the adapted intervention (RESET-CKD) to reduce
sedentary time for Black adults with CKD. In Aim 3, we will explore the lived experience of the RESET-CKD
intervention participants and identify barriers and facilitators to reducing sedentary time. These findings will be
used to inform the development of the efficacy trial that will follow this K23 award. This proposal aligns with the
National Institute of Nursing Research’s (NINR) mission to promote health equity by addressing the health
outcome inequities experienced by Black adults with CKD by adapting a sedentary reducing intervention to
meet the needs of Black adults with CKD. Under the guidance of the multidisciplinary mentoring team, the
applicant will receive training in health disparities and health equity research, clinical trial design, and mixed
methods to conduct this innovative work and expand the applicant’s program of research. Completion of this
proposal will generate data to support an R01 application to conduct a large, randomized controlled
intervention to decrease sedentary time and improve outcomes in Black adults with CKD. This K23 Award will
support the candidate’s career development as a nurse scientist by conducting mentored research focused on
decreasing sedentary behavior for Black adults with CKD in the context of the NINR Health Equity Research
Lens.

Public health relevance
Project Narrative Black adults are disproportionately affected by chronic kidney disease (CKD) and have some of the worst health outcomes among those with CKD. Sedentary behavior is associated with poor health outcomes and is an extremely common behavior in those with CKD. This project will adapt and test an intervention to reduce sedentary behavior for Black adults with CKD, which will inform the development of a future large-scale trial to reduce sedentary and improve health outcomes in this at-risk population.